Fatty Acid Binding Proteins in Macrophage Function

DESCRIPTION (provided by applicant): Fatty acid binding proteins (FABPs) act as intracellular receptors for a variety of hydrophobic ligands and are believed to play a role in lipid transport, enabling delivery of hydrophobic compounds to enzyme systems responsible for metabolism and intracellular signaling. The importance of FABPs has been underscored by recent studies in which genetically engineered mice deficient in expression of aP2 were found to display profound protection from both obesity-induced diabetes and atherosclerosis. Macrophages express high levels of adipocyte fatty acid binding protein (aP2) and keratinocyte fatty acid binding protein (mal- 1). AP2 and mal- 1 are FABPs, which have been demonstrated to bind several identified ligands for the peroxisome proliferator-activated receptors (PPARs), which include metabolites of cyclooxygenase (COX) and lipoxygenase (LOX). PPAR family members have been demonstrated to play a role in the regulation of gene expression in macrophages. Preliminary data generated using aP2 and mal- 1 deficient mice suggest that these FABPs play a basic role in the regulation of macrophage function. This proposal tests the hypothesis FABPs control the availability of PPAR ligands, thus impacting macrophage gene expression. Experiments have been designed which distinguish between a role of FABPs in sequestration of PPAR ligands versus the synthesis of PPAR ligands. PPAR activity will be assessed, and the activity of transcription factors known to be regulated by PPARS will be analyzed in wild type and FABP-deficient macrophages. The possibility that FABPs regulate availability of fatty acid precursors to LOX and COX will be evaluated via analysis of COX and LOX metabolites. Given data demonstrating reduced expression of pro-inflammatory cytokine/chemokine expression by macrophages derived from FABP-deficient mice, it is likely that the absence of aP2 and/or mal- 1 will influence the onset or progression of inflammatory disease. The experimental autoimmune encephalomyelitis (EAE) murine model of multiple sclerosis will be employed to provide a means to analyze FABP function, in vivo, in an autoimmune inflammatory response in which macrophage pro-inflammatory activity has been shown to be key to the progression of disease. These studies may reveal a unique means of modulating macrophage function for therapeutic purposes.